Structure of the TolR periplasmic domain

TolR is a part of the Pal/Tol system which forms a five member, membrane-spanning, multi-protein complex that is conserved in gram-negative bacteria. The Pal/Tol system helps maintain the integrity of the outer membrane and has been proposed to be involved in several other cellular processes including cell division. Obtaining the structure of TolR is of interest not only to help explain the many proposed functions of the Pal/Tol system, but also to gain an understanding of the TolR homologues ExbD and MotB, and to provide more targets for anti-bacterial treatments. In addition, the structure may provide insights into how colicins and bacteriophages are able to enter the cell. Therefore, we have determined the solution structure of the homodimeric periplasmic domain of TolR from Haemophilus influenzae, determined with conventional, NOE-based NMR spectroscopy, supplemented by extensive residual dipolar coupling measurements. A novel method for assembling the dimer from small angle X-ray scattering data was developed and confirms the accuracy of the NMR-derived structure. To facilitate NMR spectral analysis, a TolR construct containing residues 59-130 of the 139 residue protein was created. The periplasmic domain of TolR forms a C2-symmetric dimer consisting of a strongly curved eight-stranded beta-sheet, generating a large deep groove on one side, while four helices cover the other face of the sheet. The structure of the TolR dimer together with data from the literature suggest how the periplasmic domain of TolR is most likely oriented relative to the cytoplasmic membrane and how it may interact with other components of the Pal/Tol system, particularly TolQ.